DOSE FINDING EFFICACY OF CNS 1102 IN PATIENTS WITH ACUTE CEREBRAL ISCHEMIA

The purpose of this study is to determine the safety and tolerance of a new investigational drug which may protect the brain from more harm after stroke.